High Capacity, High Performance Storage System for Neuroscience

PROJECT SUMMARY/ABSTRACT
Contemporary neuroscience is experiencing, like many other disciplines, an ever increasing data demand due
to technological improvements in data acquisition, which continue to create data sets with higher and higher
resolution. Advancements in the acquisition of data have enabled novel interdisciplinary research efforts across
fields, but these advancements have also resulted in the need for more robust, network-aware, high-capacity
acquisition and data storage infrastructures. The Laboratory of Neuro Imaging (LONI) at the University of
Southern California (USC) has become an established frontrunner in the adoption of innovative, cutting-edge
technology to understand dynamic changes in health and disease. LONI’s collaborations have drastically
expanded over the years, and our laboratory plays a critical role in neuroscientific observational and
interventional trials and large-scale data collection efforts across institutions and countries. The increasing
availability of very high-resolution, time-varying, multidimensional data has challenged the computational
capabilities of ongoing projects in the field. To deal with large multidimensional datasets, the scientific community
requires computational systems capable of moving, storing, manipulating and rendering large volumes of data
in a practical manner. In response to these computational challenges, a group of neuro-, biomedical and
computer scientists with common interests and computational needs have come together to seek funding for the
requested instrumentation package, which will upgrade the storage infrastructure of our high performance
computational center (HPCC) resource, alleviating significant space constraints in all aspects of our
computational neuroscience investigations. The requested additional storage infrastructure will benefit many of
LONI’s collaborators both at USC and across the nation. The requested instrumentation will offer benefit to
collaborators given the: increase in storage capacity; co-localization of compute and storage; co-localization of
pre-processed and analyzed results and raw data; and staging for third party and cloud residence. An
administrative plan is already in place by which the equipment can be managed equitably. Technical and
management personnel also are part of the funded group of participants. Ongoing collaborations and the
common programmatic requirements will enable sharing of data, computer code, analytic procedures,
computational strategies and infrastructural capabilities. The requested instrument will enhance the productivity
of ongoing computational biomedical research at LONI and collaborating sites in schizophrenia, HIV/AIDS and
Alzheimer’s disease, among others, and foster the development of new technology and applications for a diverse
array of collaborators and multidisciplinary investigators.

Public health relevance
PROJECT NARRATIVE Relevance to Public Health: The Laboratory of Neuro Imaging (LONI) at the University Southern California (USC) seeks funding to address its rapidly growing data storage demands, driven by an extensive and distinguished group of local, national and international neuroscientists, computational biologists, and computer scientists with a common dedication to neuroimaging, genetics, behavioral, and bio-samples studies in health and disease. The requested instrumentation will alleviate significant storage capacity limitations detrimental to current and future investigations requiring the utilization of ever greater amounts of storage resources. If funded, ongoing neuroscience research at LONI and a significant number of collaborative efforts involving outside institutions stand to directly benefit.